Elucidating the compositional, structural and mechanical effects of Dentinogenesis Imperfecta on the Dentin-Enamel Junction

PROJECT SUMMARY:
Dentinogenesis imperfecta (DGI) affects up to 1 in 6000 individuals worldwide resulting in dental
discoloration and enamel loss. This loss often requires dental restorations but also causes these restorations
to fail. Despite these negative effects of enamel attrition, the structural/mechanical cause of the loss is
unknown. This is due to a lack of knowledge of how DGI affects the DEJ structure and local mechanical
properties. Our objective is to understand how changes in DEJ structure affect tooth fracture in DGI dentition.
In healthy dentition, the DEJ successfully connects enamel and dentin via a crack-resistant complex
graded interfacial structure. In DGI, enamel attrition suggests that the DEJ is compromised. A small body of
studies suggest that DGI both does and does not affect DEJ structure. This confusion stems from the difficulty
in measuring the DEJ’s small-scale 3D hierarchical structures. We propose to examine the DEJ in a mouse
model of DGI (Col1a2oim), which we and others have shown exhibits the key features of DGI. Using state-of-
the-art multi-scale tools we will obtain macro-, micro-, and nano-scale structural and mechanical details of
healthy and DGI-affected DEJs. These analyses will be unified into 3D models of the DEJ that will be used for
future investigations of the DEJ’s response to various restoration treatments and pathological forces. We
hypothesize that DGI will induce multiscale structural alterations in the DEJ that will cause
compromised tissue mechanics and increased risk of DEJ failure. We will test this hypothesis via 2 aims:
Aim 1: Determine how DGI affects the hierarchical structure of the DEJ
High-resolution micro-computed tomography and histology will provide macroscale structure of the
DEJ. Micron-level structure will be evaluated via Scanning Electron Microscopy tomography and Raman
spectroscopy 3D mapping. Nanoscale structures will be identified via Transmission Electron Microscopy
tomography. Together, these will provide the pieces necessary to build a cohesive structural model of healthy
and DGI-affected DEJ that can be used to elucidate DEJ function.
Aim 2: Correlate changes in mechanical properties with structure across the DEJ with DGI
Segments of DGI and wild-type (WT) incisors will be tested under compression to determine
macroscale mechanical properties. DDE and SIMPLE deformation estimation programs will identify microscale
regions of crack formation. Wide and Small-angle X-ray diffraction patterns taken across the DEJ will provide
measures of the collagen and mineral strain as a function of load and position.
Structural and mechanical data will inform each other via numerical and analytical techniques to
develop 3D models describing structure-function relationships in the DEJ. These will provide cohesive models
of both healthy and DGI-affected DEJs that will serve as future tools to predict DEJ function in terms of loads
applied during restoration treatments and reactions to pathological loading patterns during malocclusion.

Public health relevance
PROJECT NARRATIVE Dentinogenesis Imperfecta (DGI) describes a group of conditions with dental mineralization defects characterized by translucent crowns, small dentinal tubules, and enamel loss at the dentin-enamel junction (DEJ) necessitating restoration treatments. To elucidate the cause of enamel attrition in DGI dentition, we propose to investigate hierarchical structural alterations of the DEJ in a DGI mouse model (Col1a2oim) and determine how they affect DEJ mechanical function using state-of-the-art multiscale high resolution tomography and diffraction techniques. This data will be unified into cohesive and complete models of healthy and DGI-affected DEJs which will be used in the future to probe the DEJs response to pathological forces and restorative treatments.